Molecular genetics of gustatory detection

Abstract
Insects infect hundreds of millions of people annually with deadly viruses and parasites. The goal of the
proposed project is to decipher the molecular and cellular mechanisms mediating the insect sense of taste,
with the long-term goal of using these insights to develop new insect control strategies. The proposed work will
exploit the sophisticated arsenal of tools available for studying the fruit fly, Drosophila melanogaster, to
address fundamental questions in the insect taste field. The aims will employ a wide diversity of approaches,
including electrophysiology, Ca2+ imaging, behavioral assays, molecular genetics, and cell biology. The project
will leverage insights from Drosophila to attack similar problems in the mosquito, Aedes aegypti. The sense of
taste is not only essential for mosquito survival, allowing them to discriminate nutritious from dangerous foods,
but assists them in making the final decision to bite a human or fly away. Currently, the receptors that function
in mosquito taste are largely unknown. In this proposal, we outline experiments focusing on three poorly-
understood areas in insect taste: fatty acid taste, amino acid taste, and acid taste. Drosophila find low levels of
fatty acids attractive and high levels aversive. The goal of aim 1 is to decipher the receptor and neuronal
mechanisms that underlie this discrimination. We will test the model that low fatty acid levels stimulate feeding
by activating an amplification cascade initiated by a G-protein coupled receptor and culminating with a TRP
channel in cells that stimulate attraction, whereas high levels of fatty acids directly activate a TRP channel in
cells that cause repulsion. Fatty acids are potent antifeedants that suppress biting by Aedes. We will test
whether the TRP homolog in Aedes aegypti mediates this effect. Aim 2 is to define the receptor and neuronal
mechanisms underlying amino acid taste. This is important because flies must consume essential amino acids
for growth and egg production. We will test the ideas that: 1) within taste neurons of the fly tongue, a
Drosophila TRP senses amino acids in food, and 2) the same TRP detects circulating levels of amino acids in
the brain. We will also test the idea that the Aedes TRP homolog is an amino acid sensor. Aim 3 addresses the
identity of the proton channel that functions in acid taste. Low levels of some acids are attractive, but high
levels are toxic. We will test the idea that a H+ sensor is required in multiple types of taste neurons in the
Drosophila proboscis to prevent ingestion of dangerous levels of acids. Acid taste is also important in Aedes to
suppress consumption of toxic acids in food, yet carboxylic acids are present in human sweat. We will test
whether the Aedes homolog of the Drosophila H+ sensor functions in acid taste. In summary, the proposed
research will reveal the receptor mechanisms underlying poorly understood areas in Drosophila taste, and
includes the development of a key new molecular genetic tool to facilitate work in Aedes. This project has the
long-term potential to lead to the development of innovative strategies to deter biting and reduce devastating
mosquito-borne diseases.

Public health relevance
Project narrative A mosquito’s sense of taste contributes to its decision to bite human hosts. The focus of the proposed work is to discover molecules that the fruit fly uses for taste, and build on these discoveries to uncover mechanisms underlying taste in the mosquito, Aedes aegypti, which spreads dengue, zika, yellow fever and other diseases that infect millions of people each year. The long-term goal it to use these insights to develop new strategies to control the spread of insect-borne disease.